PD-L1 interacts with CD80 and PD-1 to regulate GVHD and GVL activity

Allogeneic hematopoietic cell transplantation (HCT) is a curative therapy for relapsed hematological
malignances (i.e. leukemia) due to graft-versus-leukemia (GVL) activity mediated by alloreactive T cells.
However, alloreactive T cells also mediate graft-versus-host disease (GVHD), which remains the major
obstacle for wide-spread application of allogeneic HCT. The long-term goal of our study is to develop novel
regimens that prevent GVHD while preserving GVL activity. PD-L1 interacts with CD80 and PD-1. Although
PD-L1/PD-1 regulation of immune responses plays an important role in animal models and humans, the role of
PD-L1/CD80 remains largely unknown. Our recent publication in JCI has shed light on the importance of PD-
L1/CD80 interactions. Our studies indicate that the outcome of PD-L1-mediated signaling in CD8+ T cells
depends on the presence or absence of CD4+ T cells, the nature of the interacting receptors (i.e. CD80 versus
PD-1) expressed by CD8+ T cells and the tissue environment (i.e. lymphoid versus parenchymal tissues) in
which the signaling occurs. We observed that, in the absence of donor CD4+ T cells, CD8+ T-T interactions via
PD-L1/CD80 augmented naïve/activating CD8+ T proliferation and survival in lymphoid tissues, leading to
strong GVL activity. In contrast, host-tissue PD-L1 interactions with PD-1 and CD80 on CD8+ T cells in GVHD
target tissues induced their proliferation and apoptosis, leading to prevention of GVHD. Donor CD4+ T cells
helped CD8+ T cells via IL-2 become resistant against tissue PD-L1-mediated tolerance. Agonistic PD-L1-Ig
binding to both CD80 and PD-1 augmented activated T cell proliferation and apoptosis. Conflicting results have
been reported regarding the effects of glycolysis and oxidative phosphorylation (OXPHOS) in alloreactive T
cells during the pathogenesis of acute GVHD. In kinetic studies, we observed that expression of CD80 and PD-
1 was associated with shift from glycolysis to OXPHOS. Therefore, we hypothesize that 1) PD-L1/CD80 and
PD-L1/PD-1 interactions reciprocally regulate T cell glycolysis and OXPHOS, and the outcome depends
on the tissue environment, due to differential T cell expression of CD80, PD-1, and PD-L1; 2) Reduction
of serum IL-2 will increase the sensitivity of T cells towards tissue PD-L1-mediated or agonistic PD-L1-
Ig-mediated tolerance in association with metabolic profile changes. The proposed studies will dissect the
mechanisms by which PD-L1/CD80 interactions regulate glycolysis and OXPHOS in naïve/activating and
activated T cells in lymphoid and GVHD target tissues (Aim 1). We will also design a regimen of sequentially
administered anti-IL-2 and agonistic PD-L1-Ig to prevent GVHD and preserve strong GVL activity (Aim 2).
These studies will reveal novel insights into T cell biology and GVHD pathogenesis and could lead to
development of novel regimens that prevent GVHD while preserving GVL activity in humans.
1

Public health relevance
Narrative Allogeneic hematopoietic cell transplantation (HCT) is a curative therapy for hematological malignancies due to the graft versus leukemia/lymphoma (GVL) effects mediated by alloreactive T cells. However, alloreactive T cells also mediate a severe side effect, graft versus host disease (GVHD), which remains the major obstacle for a wide-spread application of allogeneic HCT. Prevention of GVHD while preserving GVL effects remains the holy grail of allogeneic HCT. We have observed that immune check points PD-L1/CD80 and PD-L1/PD-1 not only can be manipulated to augment but also can be manipulated to down-regulate immune response. The proposed studies will explore in depth mechanisms how PD-L1/CD80 and PD-L1/PD-1 signaling regulates alloreactive T cell metabolism, proliferation, and apoptosis, as well as explore how to manipulate these pathways for prevention of GVHD while preserving GVL effects.